Data Management and Analysis Core

PROJECT SUMMARY/ABSTRACT
The Data Management and Analysis Core (DMAC) will coordinate data management and analysis within the
Michigan State University Superfund Research Center (MSU SRC) to support the identification of sensitive
populations and reduce exposure to toxic aryl hydrocarbon receptor (AHR) ligands. Implementation of a
comprehensive data management and analysis plan (DMAP) will encourage data sharing and interoperability,
and promote the Findable, Accessible, Interoperable, and Reusable (FAIR) guiding principles. DMAC will
facilitate the collection of MSU SRC data sets into a center-based data commons to support data exploration,
visualization, and analysis. Using established minimum information requirement standards and ontologies,
DMAC will capture the essential information required to enable reproduction of the processes used to create and
analyze MSU SRC datasets, and facilitate reproducible results for the translation of research to practice. Data
quality assurance processes will ensure sharing of high quality data between projects and cores, as well as with
other centers and stakeholders. To accomplish these objectives, DMAC will: (i) Implement the Investigation
Study Assay (ISA) framework for the collection of data and metadata from projects and cores. This framework
promotes the use of data standards and ontologies which are critical for the application of FAIR principles. The
ISA infrastructure will be used to collect, validate, and archive all data produced by the MSU SRC. (ii) Establish
a center-based data commons using the open source Gen3 data commons framework which co-locates data,
analysis tools, and computational resources. The data commons will enhance data interoperability and sharing
through a web-based user interface and standardized data model, and will be used to integrate the disparate
datasets generated by the SRC. (ii) Institute quality assurance and quality control procedures and processes to
assure data set integrity, and that curated data sets are consistently used and understood across all projects
and cores, and (iv) Provide center-wide training in data management and analysis principles. Training activities
will be organized with the Research Experience Training Coordination Core (RETCC) to inform project leaders
and trainees about optimal data management practices and procedures. Accomplishing these aims will foster
data science approaches by assuring MSU SRC data can be found, accessed, and independently interpreted
with the overall objective that data can be successfully used and reused in an interoperable manner. In summary,
DMAC will work closely with projects and cores to facilitate: curation and sharing of data sets and analyses;
training of MSU SRC staff; mentoring of trainees in best data management practices; and facilitate translation of
research data processes into practice.

Public health relevance
PROJECT NARRATIVE The MSU SRC Data Management and Analysis Core (DMAC) will support effective data management and data science-based analysis through the implementation of a comprehensive data management and analysis plan. This will involve: 1) facilitating coordination between projects and cores to foster data science approaches for identifying new associations within disparate data that lead to the formation of new hypotheses, 2) enabling data sharing between MSU SRC projects and cores, as well as external stakeholders, and interoperability with external repositories, 3) implementing data quality assurance and quality control procedures and processes, and 4) providing center-wide training regarding data management and analysis principles.